Selective pressures from inherited variation impacting myeloproliferative neoplasm initiation

Project Summary/ Abstract
While substantial progress has been made to delineate the somatic mutations that drive myeloproliferative
neoplasms (MPNs), epidemiologic studies demonstrate a significant heritable risk for disease acquisition. We
have recently conducted the largest genome-wide association study of MPNs to define inherited risk variants
that promote the acquisition of this disease. Our initial analyses suggest a role for modulation of HSC self-
renewal and function by these inherited risk variants. However, we lack a complete mechanistic understanding
of how the selective pressures that arise from these inherited variants can promote MPN acquisition. Here, in
this R01, we specifically want to understand how inherited risk variants can provide selective pressures to enable
MPN initiation. In the first aim of this grant, we seek to use rigorous mouse models to define how a variant-
containing HSC-selective enhancer of Gfi1b can promote MPN acquisition. We will study how this enhancer
plays a role in native hematopoiesis to promote MPN initiation, as well as how this enhancer can cooperate with
somatic mutations in this process. In the second aim of this grant, we seek to understand how loss-of-function
of CHEK2 can promote MPN acquisition and clonal hematopoiesis by coupling genome editing of primary human
hematopoietic stem/ progenitor cells and whole genome sequencing to assess how such germline genetic
mutations can promote oncogenesis. Finally, in the third aim, we seek to more holistically define how variant-
harboring regulatory elements and target genes may play a role in HSC self-renewal and function through the
use of a multiplexed guide-swap Cas9 genome editing approach in primary human hematopoietic stem and
progenitor cells. Collectively, the studies we propose in this grant will provide new insights into how inherited risk
variants can provide selection pressures that enable MPNs to arise.

Public health relevance
Narrative Individuals can be predisposed to specific cancers, such as blood cancers, by inherited variation. We have begun to define this variation, but we do not understand why it can predispose individuals to acquire blood cancers. In this grant, we will study the pressures that arise from these inherited risk variants that promote blood cancer emergence.